Genomics Core

GENOMICS CORE: SUMMARY
The Genomics Core will provide centralized expertise and instrumentation for all three projects, specifically
library preparation, short-read and long-read sequencing, as well as data storage and distribution. This
centralization of resources will result in economies of scale as well as standardization of protocol and sequencing
platforms. The Genomics Core will be led by Dr. Adriana Heguy, PhD, Professor of Pathology at the NYU
Grossman School of Medicine and Director of the Genome Technology Center (GTC) at NYU Langone Health.
She is an internationally known genomics scientist with >16 years running genomics facilities for cancer
research. Her lab is a state-of-the-art genomic facility specializing in library preparation for short-read and long-
read sequencing for numerous applications of transcriptomics, genomics and epigenomics research, including
RNA-Seq and scRNA-Seq, multiple chromatin conformation sequencing modalities such as Hi-C and Hi-ChIP,
ChIP-Seq/Cut&Tag, ATAC-Seq, and whole genome sequencing, as well as many others. Key instrumentation
includes 3 NovaSeq 6000, 1 NextSeq 2000, and the newest PromethION 24, and 4 liquid handlers from Tecan,
Beckman and Hamilton for high throughput automated RNA-Seq, scRNASeq and other library prep modalities.
Dr. Heguy has worked extensively with Drs. Skok, Aifantis and Melnick during the past 4 years of the P01,
generating key data featured in numerous high impact publications. The specific aims of the Genomics Core are:
1) to provide chromatin profiling and conformation library preparation (ChIP-Seq/Cut&Tag and ATAC-Seq,
scATAC-Seq, Hi-C, Hi-ChIP, 4-C, Capture Hi-C) and sequencing; 2) to provide transcriptome profiling (RNA-
Seq, scRNA-Seq, Perturb-Seq); 3) to perform long-read Pore-C and Nano-NOME-Seq; and 4) to facilitate data
management, sharing and storage among all projects and the Computational Core, through high performance
computing (HPC) resources. The Genomics Core will extend beyond the current capabilities of GTC, which is a
shared resource partly supported by an NCI Cancer Center Support Grant. The Skok, Aifantis and Melnick labs
will assist the Genomics Core with the standardization of long-read chromatin conformation library prep
protocols, specifically Nano-NOMe-Seq, Pore C and Perturb-Seq. The Genomics Core will coordinate sample
workflow with the Pathology Core, and after sequencing, with the Computational Core, with which the GTC is
already seamlessly integrated. There will be two half FTEs dedicated to the generation of data for these three
projects, and Dr. Heguy’s effort at 10%.

Public health relevance
GENOMICS CORE: NARRATIVE The Genomics Core will support the research of the three projects in this P01 by processing all samples to generate genomic data. Genomic data in this application means information about the genes expressed in each sample, as well as the chromatin state of the cells, which regulates how genes are expressed. Genomic data generated by this Core will be used to further advance our understanding of genomic and chromatin dysregulation in cancer, with the ultimate goal of development of novel therapies to treat hematological cancers.